Mentoring and Research in Integrative Medicine

PROJECT SUMMARY
This is a proposed renewal of a highly successful K24 award for Dr. Frederick Hecht, Professor of Medicine at
the University of California (UCSF), and director of research at the UCSF Osher Center for Integrative
Medicine. Dr. Hecht is an internist with postdoctoral training in clinical epidemiology, who is a leader in
research on mindfulness-based interventions and health. He directs the T32-funded UCSF Training in
Research in Integrative Medicine (TRIM) fellowship program, and is principal investigator for two NCCIH
research grants. He has mentored more than 40 postdoctoral fellows and junior faculty and published over 200
peer-reviewed articles. In the initial K24 period, Dr. Hecht has mentored 12 pre/postdoctoral fellows and 10
junior faculty on K awards. With this K24 renewal, Dr. Hecht aims to mentor at least four postdoctoral and two
predoctoral fellows each year, and four to six junior faculty with K awards. He will further develop his research
and mentoring capabilities with advanced seminars on research design and biostatistics. UCSF provides an
extremely rich and supportive scientific environment for Dr. Hecht's research and that of his mentees, including
an outstanding NIH funded CTSA, which is closely integrated with Dr. Hecht's K24 plans. The specific research
aims of Dr. Hecht's research program are to: (1) develop and test innovative applications of mindfulness-based
interventions and tools for studying the active components of these interventions, (2) assess the mechanisms
of action of integrative medicine therapies, and (3) test the benefits of integrative medicine therapies such as
acupuncture/acupressure and yoga in decreasing pain and improving symptom management. In this K-24
renewal, Dr. Hecht will continue to focus his research and mentoring on some of our most important chronic
health problems, including obesity, pain, and diabetes, applying innovative methodological approaches such as
adaptive interventions to optimize integrative medicine based interventions for treatment and prevention of
these conditions. With this renewal, he aims to continue providing mentoring and a research environment to
develop an exceptionally strong and diverse group of researchers who will play leading roles in the future of
integrative medicine research.

Public health relevance
PROJECT NARRATIVE Integrative medicine approaches have important potential to improve treatment for some of our most important chronic health problems, including obesity, pain, and diabetes. This K24 proposal will support mentoring and a research environment to develop a new generation of researchers who can advance research on integrative medicine approaches to these important health problems.